TSA SIB-PAIR STUDY

The hypothesis of this study is based on the following: the genetic defect of TS can be localised by applying themolecular genetic technique of sib- pair analysis to data gathered from families with multiple affected children.